Mentoring Patient-Oriented Clinical Investigators in Nephrology

PROJECT SUMMARY
This is a renewal K24 application for an established and decidedly mid-career clinical
investigator who was highly successful in achieving the goals of the K24 program during his first
award. Before and since the first K24 was awarded, Dr. Chertow has been among the most
productive mentors in nephrology by any metric. Dr. Chertow has been among the most
productive mentors in nephrology by any metric. Dr. Chertow has had the privilege of
mentoring or co-mentoring more than 30 junior faculty, fellows, residents and students
(medical, graduate and undergraduate), nearly all of whom remain in academics. Three of his
former trainees are Division Chiefs; several are in established research-oriented faculty
positions at leading universities and have secured multiple R01 or U01 awards. Other, younger
trainees have obtained K23 or other career development awards. He has published scores of
manuscripts with his mentees as lead author. Over the next five years, Dr. Chertow hopes to
enhance his mentoring skills through advanced didactic training in health policy and health
economics, and with involvement in policy-relevant activities within and outside of Stanford
University. Protected time for career development, research, and mentoring will allow Dr.
Chertow to broaden the scope and influence of his and his trainees' work, and help to sustain
and grow the patient-oriented research enterprise of the NIDDK.

Public health relevance
PROJECT NARRATIVE Dr. Chertow has established a successful career in patient-oriented research. He previously received a mid-career investigator award (K24) and during that time, helped to train several young investigators at different career stages. He now hopes to renew the K24, enhance his mentoring skills, and broaden the scope and influence of his trainees’ work.